Developing an Integrative, Recovery-Based, Post-Acute COVID-19 Syndrome (PACS) Psychotherapeutic Intervention

Project Abstract
At present, 34.6 million people in the United States, and 273,232 Veterans tested or treated in Veteran Affairs
facilities contracted COVID-19. While the exact prevalence of Post-Acute COVID-19 Syndrome (PACS) among
Veterans is unknown, estimates of psychiatric/neurological PACS using a large global sample of COVID-19
patients (N=236,379) suggest a prevalence of approximately 11,390,400 Americans, and 90,311 Veterans in
VA care, with rates likely to increase over time. Moreover, large scale studies suggest up to 35% of individuals
experience functional impairment 8 months after COVID-19, and high prevalence of post-infection mental illness
including anxiety disorders, depression, and post-traumatic stress disorder. Using longitudinal data from our
academic affiliate, Icahn School of Medicine at Mount Sinai’s COVID registry (n≈1200), and local James J. Peters
VA’s Clinical PACS program, coupled with our expertise in recovery-based psychotherapy, we are uniquely
poised to develop an innovative treatment for Veterans struggling with PACS.
Our intervention aims to improve psychological adjustment to PACS symptoms, promote resiliency, and facilitate
coping, all of which can impact functional status and quality of life. The PACS-Coping and Recovery (PACS-CR)
intervention we aim to develop focuses on psychological adjustment and coping, and augments medical,
rehabilitative and neurological treatment for this population. Our approach is based on the CHIME model of
personal recovery which includes five overarching processes: 1) Connectedness; 2) Hope and optimism about
the future; 3) Identity; 4) Meaning in life; and 5) Empowerment. We will target the CHIME processes using
established psychotherapeutic techniques such as skills training, acceptance-based and identity-based
principles.
Based on adaptations from existing recovery-based and COVID-19 distress group interventions that our team
has developed and piloted, we are proposing a treatment framework that consists of a core of twelve 90-minutes
sessions (1x/week x 12 weeks) with additional weekly sessions on specialized topics that are optional. We are
proposing a treatment development NIH Stage 1A study to develop a Post-Acute COVID-19 Syndrome
psychotherapeutic intervention, “PACS Coping and Recovery” (PACS-CR) through an iterative development
process while collecting pilot data to assess its acceptability and feasibility.
Our treatment development SPiRE will focus on 1) determining the treatment needs of Veterans with PACS, 2)
developing the treatment using pilot qualitative data and aided by stakeholder feedback, 3) refining the
intervention by three iterative pilots of our groups, testing both in person and telehealth versions. Pre and post
measures will be utilized to track functional improvement and the degree to which this recovery-focused
intervention has enabled the veterans to engage in meaningful life changes.

Public health relevance
Project Narrative The proposed treatment development NIH Stage 1A study aims to develop a Post-Acute COVID-19 Syndrome (PACS) psychotherapeutic intervention, PACS Coping and Recovery (PACS-CR) through an iterative development process while collecting pilot data to assess its acceptability and feasibility. Many COVID-positive individuals continue to experience symptoms that include prolonged fatigue, impairment of memory, concentration disorder, headache, pain, insomnia, anxiety, post-traumatic stress disorder (PTSD), and depression, which can significantly disrupt function and quality of life, and for which empirically validated treatments have yet to be developed. PACS-CR aims to address these issues through a novel, integrative, recovery-focused psychotherapeutic group intervention that incorporates established skills-based techniques with optional topical groups co-led by specialist providers.